Role of satellite cells in microvascular recovery during skeletal muscle regeneration

Project Summary
Skeletal muscle has the remarkable ability to repair itself following injury through activation, proliferation, and
differentiation of resident stem cells (satellite cells, SCs). Acute injury destroys capillary networks and abolishes
perfusion coincident with myofiber degeneration. Although the cellular and molecular events of myofiber
regeneration are well defined, little is known of corresponding events in the regenerating microvasculature. To
address this gap in knowledge, local injection of the myotoxin BaCl2 is used to initiate degeneration and
regeneration in the gluteus maximus muscle (GM) of adult (~4 mo) male and female mice. Surviving endothelial
cell (EC) segments sprout within 2-3 days post injury (d PI) then elongate and fuse into new capillary networks
that become perfused by 5d PI, which coincides with the initial stages of myofiber regeneration. Despite their
intimate association and concurrent activation, crosstalk between myogenesis and microvascular regeneration
is poorly understood. The central hypothesis of this project is that paracrine signaling from SC progeny is
integral to the regeneration and stabilization of microvascular networks. Transgenic mice in which SCs have
been depleted prior to injury, and therefore cannot regenerate myofibers, will be used. Preliminary data show
that microvascular density is reduced following injury in the absence of myogenesis when compared to wild-type
mice. Thus, confocal microscopy and flow cytometry will be used to determine whether myogenesis controls
endothelial tip cell selection, proliferation, and/or survival as the basis for this attenuated angiogenic response
after injury (Aim 1). Confocal imaging and immunostaining of whole mount GM for tip cell markers (e.g., VEGFR2)
will assess the magnitude of EC sprouting; proliferation of ECs will be analyzed in vivo with EdU. In addition,
primary ECs will be isolated from injured GM to determine the extent of endothelial cell cycle progression and
apoptosis-mediated vascular pruning using fluorescence activated cell sorting. In Aim 2, the role of myogenesis
in the regulation of the endothelial permeability barrier will be tested because the diffusional exchange of oxygen,
nutrients, and metabolic byproducts between myofibers and their microvascular supply is integral in restoring
and maintaining tissue homeostasis. Because barrier integrity recovers early in regeneration in wild-type mice
but remains leaky in the absence of myogenesis, pericyte (PC) integration into the nascent microvascular wall
and organization of VE-cadherin based intercellular junctions will be evaluated by immunostaining in whole GM;
both components are essential for tight EC-EC junctions. Experiments using conditioned medium from myogenic
cells will investigate the direct and indirect regulation of intercellular junctions through paracrine signaling in vitro.
Results from these studies will provide critical new insight into how myogenesis affects both the initial
microvascular regeneration and long-term stabilization of networks after muscle injury. This project represents a
critical step towards developing novel therapies to promote muscle recovery from trauma, ischemia, and disease.

Public health relevance
Project Narrative Following skeletal muscle injury and degeneration, myofibers and microvessels must regenerate to restore tissue integrity and contractile function. This research project will investigate the role of muscle stem cells (“satellite cells”) in the recovery of microvascular structure and function following acute injury. Advancing our understanding of the intercellular signals that restore the supply of oxygen and nutrients from the microcirculation will improve the treatment of muscle injury from trauma, ischemia, aging, and disease.